Designing safe, potent, and cost-effective small peptide erythropoietin analogs

Recombinant human erythropoietin (rhEpo) has proven to be an effective treatment of anemias,
primarily those secondary to renal disease and malignancy. The cost of rhEpo therapy, the need
for frequent parenteral administration, the development in some patients of anti-Epo antibodies,
and an associated increase in thromboembolic events (relative risk ratio of 1.67) suggest a real
need for a cheaper, safer, and more conveniently deliverable therapeutic. Therefore, we have
developed and preliminarily tested with in vivo model, a short peptide epo analog based on
peginesatide, a previously FDA approved peptide epo agonist. Our new lead molecules have
been optimized to avoid any immunogenicity. This Phase 1 SBIR proposal will further develop
this therapeutic by identifying the best compound tuned for weekly dosing and establishing its
therapeutic in vivo proof of concept. This work will be articulated around 3 aims: (Aim 1) Determine
the structural scaffold to attain in vitro stability and optimization of the weak metabolic centers by
modifying lead molecules. (Aim 2) Determine the structural features that will provide in vitro and
in vivo PK profiles to enable weekly delivery as our minimum benchmark. (Aim 3) Confirm the in
vivo PK profile matching the goal of weekly administration and in vivo efficacy in mice treated
weekly with vehicle vs. drugs selected from Aims 1 and 2. When these milestones are
accomplished, new compounds will be ready to enter the pre-IND phase of therapeutic
development.

Public health relevance
The cost of Recombinant human erythropoietin (rhEpo) therapy is a significant concern and often dissuades physicians from prescribing. This proposal will optimize our lead, more economical, and safer short-peptide epo analog to address this need.